Dynamic modeling of antagonism between enteric infection and undernutritionin infancy

PROJECT SUMMARY
The goal of this NIAID Mentored Research Scientist Development Award (K01) is to provide the candidate,
Gwenyth O. Lee, with the training and protected time to build an independent, interdisciplinary research program.
This program would bridge computational modeling methods and community-based research to address key
questions in the field of enteric disease epidemiology. Stunted growth is a significant negative outcome of
frequent enteric infection among children under five years in low and middle- income countries (LMICs). A major
obstacle to the development of impactful interventions to prevent stunting has been methodological. Growth
faltering in children is the cumulative result of complex interactions between infectious exposures and dietary
inadequacies. Conventional statistical approaches are capable of, but not well-suited to, disentangling these
interactions to identify those modifiable factors with the greatest potential impact. On the other hand, systems
approaches are explicitly designed to capture complex interactions between multiple causal relationships.
Therefore, the overall objective of this proposal is to develop a mechanistic model that captures patterns of
feedback between infection, diet, and short-term growth dynamics and predicts how an individual infant might
grow, given different patterns of infection experienced in the first two years of life. This model will be used to test
whether feedback between infection and undernutrition has the potential to result in a ‘tipping point’, such that
enteric infections impact stunting only when the negative effect of these infections outpaces the infant’s biological
capacity for catch-up growth. The model will also be used to investigate mechanisms by which dietary
inadequacies modify the relationship between enteric infections and growth and to compare enteropathogen-
specific growth impacts. The model will be empirically based in 1) data from three Ecuadorian birth cohorts,
sampled across rural-urban gradient with variable burdens of enteric exposures but relatively homogenous infant
feeding practices and 2) data from six birth cohorts from multiple LMIC contexts (‘MAL-ED’ study), where enteric
exposures but also dietary and social conditions are heterogeneous between cohorts. To match the proposed
scientific work, the candidate will seek to integrate her experience in community-based enteric disease research
with the following training areas: computational modeling, including 1) system dynamics and 2) agent-based
modeling, and 3) the nutritional regulation of child growth.
This training will be augmented with 4) career-building
activities to acquire essential tools for leadership and professional growth. Experts have emphasized the need
to better integrate computational modeling into applied epidemiology research, thereby creating models that can
better predict contextually-tailored intervention strategies. The project builds upon the unique resources and
mentoring available to the candidate through the University of Michigan to provide advanced methodological
training, bolster applications for competitive funding, disseminate findings across the wider research community
and attain research independence.

Public health relevance
PROJECT NARRATIVE This research addresses a central challenge in current global health research, the burden of stunting among infants in low- and middle-income countries facing a high burden of enteric infection. With this award, I will build an independent, interdisciplinary research program that bridges community-based enteric disease research and advanced computational modeling methods for systems epidemiology. This research will inform interventions to reduce the burden of infectious diseases on infants and children living in low- and middle-income countries.